Program on Occupational Health and Safety Education on Emerging Technologies - Mid Atlantic Partnership (POccET MAP)

PROJECT SUMMARY
Many emerging technologies are becoming increasing ubiquitous in workplaces as well as non-occupational
settings such as commercial and residential environments. While there are obvious benefits to these
technologies, unintended exposures and risks from their use are becoming increasingly apparent. Fostering
the safe and sustainable development and use of these technologies requires a critical mass of professionals
and researchers with the interdisciplinary education, training, and adaptability to tackle these occupational
health and safety (OHS) issues. Johns Hopkins University, the University of Maryland, George Mason
University, and Old Dominion University propose to work collaboratively on the Program on Occupational
health and safety education on Emerging Technologies – Mid Atlantic Partnership (POccETMAP) to
develop a comprehensive set of web-based educational and training modules, courses, and programs to foster
the safe development and use of emerging technologies and mitigate their risks, emerging contaminants, and
disaster preparedness. To accomplish this objective, we will develop five online cores for professional training
of OHS specialists, engineers, scientists, technicians, and instructors in the areas of (a) Detection
Technologies for emerging contaminants; (b) Exposure assessment strategies; (c) Disaster preparedness and
risk management; (d) Vulnerable occupational populations, and (e) Sustainable production and product
stewardship of emerging technologies. In the cores, we will demonstrate concepts with examples and
illustrations drawn from the following emerging technologies: additive manufacturing such as 3-D printing,
novel technologies for disinfection, electronic nicotine delivery systems, and nanobiotechnology. Each core will
contain 10 innovative, web-based modules that include short narrated screencasts, animations, exercises, and
activities. Instructors will use the modules to create lessons, courses, and programs in academic and
continuing education settings. All materials will be freely available on the web, ensuring that the POccETMAP
Program has a regional, national, and global reach. This innovative program and its educational products will
target industrial hygiene students; students in other science, engineering, and technology disciplines; and
professionals who require continuing education on the health and safety of emerging technologies.

Public health relevance
PROJECT NARRATIVE The Program on Occupational health and safety education on Emerging Technologies – Mid Atlantic Partnership (POccETMAP) is collaborative effort between multiple institutions to develop and widely distribute a web-based curriculum to prepare students in industrial hygiene, STEM disciplines, and OHS professionals with the skills necessary to address health and safety issues that arise in emerging technology areas including additive manufacturing such as 3-D printing, novel technologies for disinfection, electronic nicotine delivery systems, and nanobiotechnology.